Sociocultural Stressors, Resilience Factors, and Arterial Stiffness in Perimenopausal Latinas

PROJECT SUMMARY/ABSTRACT
There is extensive evidence that the risk of cardiovascular disease (CVD), the leading cause of death for women,
increases during perimenopause (PM), a crucial midlife stage of 4-8 years around the final menstrual period
characterized by hormonal alterations as well as adverse changes in stress levels and vascular health. Notably,
Latinas experience menopause 1-2 years earlier than non-Latina White women and have a greater prevalence of CVD
risk factors (e.g., obesity, diabetes), yet remain underrepresented in menopause research. Arterial stiffness is a
non-invasive subclinical marker predictive of CVD events that accelerates dramatically during perimenopause.
The marginalized status of Latinas in the United States exposes them to sociocultural stressors—including
acculturative stress, ethnic discrimination, family obligation stress, and neighborhood disadvantage—shown to
increase arterial stiffness. Resilience factors (e.g., self-compassion, positive attitudes towards menopause,
social support, social cohesion) have been shown to exert some protection against the adverse changes that
occur during perimenopause, including stress and CVD risk. The overall goal of this study is to identify
sociocultural stressors associated with arterial stiffness progression in Latinas during perimenopause and
evaluate the role of resilience factors (i.e., self-compassion, positive attitude towards menopause, social support,
and social cohesion) in these associations. Secondary aims include testing whether allostatic load mediates
associations of sociocultural stressors and resilience factors with arterial stiffness progression. To accomplish
this goal, we propose a longitudinal observational study with 300 perimenopausal Latinas (aged 40-60).
Participants will complete four study visits over 6-month intervals (0, 6, 12, and 18 months). All women will
undergo carotid-femoral pulse wave velocity (cfPWV) assessment for arterial stiffness. Culturally-specific
measures will be used at each visit to assess sociocultural stressors and resilience factors. The allostatic load
will be assessed using 13 biomarkers (e.g., body mass index, waist-hip ratio, blood pressure, heart rate, fasting
glucose, lipid profile, C-reactive protein, cortisol, dehydroepiandrosterone sulfate). Relations between
sociocultural stressors and resilience factors with arterial stiffness progression will be examined using linear
mixed models. This study is the first study to longitudinally examine associations between sociocultural stressors
and resilience factors with arterial stiffness in Latinas during perimenopause. The proposed study is a critical
first step in better understanding sociocultural risk and protective factors of cardiovascular health in midlife
Latinas. Addressing these aims may inform the development of culturally-tailored multilevel psychosocial
interventions to reduce the CVD risk of Latinas during perimenopause.

Public health relevance
PROJECT NARRATIVE Menopause is a major health milestone for women that is characterized by multiple physiological and psychosocial changes that shape the development of cardiovascular disease, particularly among Latinas, who experience a higher burden of stress and CVD. This study aims to better understand sociocultural risk and protective factors (e.g., acculturative stress, ethnic discrimination, self-compassion, social support) of cardiovascular health in perimenopausal Latinas. Since Latinos are the largest ethnic minority in the United States, progress toward the early identification and prevention of CVD among Latinas may lead to significant improvement in the overall CVD burden in the United States.